Unveiling Marine Lanthipeptides: From Biosynthesis to Antibiotic Potential Against Antimicrobial Resistant Pathogens

PROJECT SUMMARY
Nature remains the most lucrative resource for identifying new bioactive molecules for pharmacological
applications. Identification of unique chemical scaffolds and new bacterial reservoirs for antibacterial natural
products is required to reinvigorate the antibiotic discovery pipeline. Lanthipeptides are a class of natural
products that frequently display potent antimicrobial activity with low susceptibility to antimicrobial resistance
mechanisms, but an incomplete understanding of their biosynthesis and structure function relationships is
creating a bottleneck between their antimicrobial potential and application as antibiotic therapies. Broader
characterization of novel lanthipeptide scaffolds and the enzymes catalyzing their biosynthesis is needed to
convert this untapped reservoir of bioactive natural products into antibiotic therapies. Genome mining
approaches enable facile identification of an organism’s biosynthetic potential and have been used to
demonstrate the importance of marine bacteria as untapped reservoirs for natural product discovery, including
novel lanthipeptides. Two adjacent lanthipeptide biosynthetic gene clusters in an ecologically important species
of marine bacteria were identified, with one of these clusters encoding for a predicted halogenase, which is a
highly valuable catalyst in medical chemistry. The objective of this proposal is to structurally elucidate the
lanthipeptide products produced by these novel biosynthetic gene clusters, test their antibiotic
potential, and determine the substrate specificity of the halogenase involved in their biosynthesis.
Indeed, the long-term goal is to contribute to the development of a molecular toolkit that can be used to
engineer lanthipeptides into “unnatural natural products” with antibiotic activity. In Aim 1, ecological conditions
resulting from host-microbial interactions will be used to trigger lanthipeptide production from the native marine
bacterial species, allowing comparative metabolomics to be used to infer their chemical composition from wild
type culture supernatants compared to deletion mutants. In Aim 2, the halogenase encoded within one of the
lanthipeptide biosynthetic gene clusters will be co-expressed with wild type and mutated lanthipeptide
precursor peptides along with their cognate biosynthesis enzymes. The resulting tailored peptides will be
subject to chemical analysis to determine the range of substrate specificity of the tailoring enzyme. In Aim 3,
lanthipeptide products, at varying stages of maturity, will be tested for antimicrobial activity against a panel of
Gram positive and negative bacteria, and their mechanisms of action determined, as well as their suitability to
act as adjuvants to restore antibiotic potency and reverse resistance. This proposal design embraces
resources from a marine microbe whose well-established chemically mediated microbiome interactions have
likely contributed to the evolution of new lanthipeptide scaffolds and halogenation machinery that can be
exploited for new to nature pharmacophores.

Public health relevance
PROJECT NARRATIVE The rise in antibiotic resistance among human pathogens paired with the shortage of new drug leads entering the antibiotic pipeline has created a public health crisis requiring novel antimicrobials to be identified from currently unexplored or underexploited sources. Lanthipeptides are a class of natural products that exhibit potent antimicrobial activity as a consequence of their unique structures and mechanisms of action, but require further study and engineering to improve their therapeutic potential. The application seeks to characterize products and select biosynthesis enzymes from two novel adjacent lanthipeptide biosynthetic gene clusters encoded by an ecologically significant species of marine bacteria, ultimately providing the community with additional biological building blocks to accelerate the development of new antimicrobial therapies.